Patient tailored near real-time image-based treatment for interstitial PDT of Inoperable Cancer with Airway Obstruction - Phase IIa

Abstract
To establish the efficacy of interstitial photodynamic therapy (I-PDT) for solid cancer treatments, the
treating physician needs to be able to tailor the treatments to each patient. During I-PDT in the clinic, there is a
need to adjust the irradiance (light dose rate) and fluence (light dose) to account for patient-specific tissue and
tumor optical properties and to account for changes in fiber placements that occur after an initial pretreatment
plan is generated. This can be accomplished with the novel, near real-time computational software, DOSIETM,
developed by Simphotek, Inc. The DOSIE key advantages are: (i) it is a dedicated single-package software
package for computing dose metrics of intratumoral light irradiance and fluence for I-PDT; and (ii) it includes a
fast algorithm for updating the laser light settings according to optical properties of the tumor and actual fiber
placement in near real-time. To demonstrate that DOSIE can effectively guide I-PDT, Simphotek and RP propose
to conduct a pilot Phase II clinical study (Phase IIa) on patients with solid malignancies in the lung causing central
airway obstruction involving extrinsic tumor growth and related airway compression. The proposed trial will utilize
endobronchial ultrasound (EBUS) with a transbronchial needle (TBN) that will be used to guide optical diffuser
fiber insertion for intratumoral illumination in I-PDT. The DOSIE treatment planning system that will be employed
in this trial is vital to calculate the intratumoral fluence and irradiance, which will impact tumor response in I-PDT
of the locally advanced cancers.

Public health relevance
The general lack of effective treatment planning tools that can provide patients with individualized cancer treatments is a critical barrier to continued progress in interstitial photodynamic therapy (I-PDT). Simphotek, Inc. proposes to fill this unmet need by developing unique prototype software and hardware tools that can be easily utilized by I-PDT physicians in the clinic. Effective I-PDT treatment planning is expected to improve patient outcomes, reduce the occurrence of under- and over-exposure treatments and therefore reduce overall costs in cancer-related therapy.